CLINICAL AND IMAGING CORE SUPPORT OF ACUTE STROKE RESEARCH

The foundation of an acute stroke translational research program is an acute stroke clinical service that will assure maximum patient referral and allow rapid identification, screening and recruitment of potential research subjects in the timely fashion needed to study the early events in cerebral ischemia and enroll patients in acute stroke research protocols. Absence of an emergency department and the time constraints on screening and recruitment of acute stroke patients as research subjects has precluded the NIH Clinical Center as the main site of our research projects. Thus, we have needed to establish and maintain the clinical, imaging and research infrastructure required to support such a program at local hospitals, Suburban Hospital (SH) in Bethesda, Maryland, and Washington Hospital Center (WHC) in DC. The major elements of this infrastructure include the NIH Stroke Service, a combination of NIH and contractor clinicians stroke neurologists, nurses, clinical fellows, on-site research/nurse coordinators and MRI technologists. The NIH computer network has been extended to each site. In addition NIH has placed a 3T MRI scanner at WHC and shares a 3T MRI scanner at SH. We maintain our own PACS for images obtained on the WHC and SH MRI scanners, and developed and maintain a registry for clinical and research patient data. In the past year we screened approximately 1000 patients and enrolled approximately 160 patients into one of our clinical research protocols.